SUPPORT FOR THE 2015-2016 CLINICAL RESEARCH REPRODUCTIVE SCIENTIST TRAINING (CREST PROGRAM)

This project is for the delivery of a 20 week web-based educational program in clinical research design and biostatisitics specially designed for reproductive medicine trainees. Consulting with CREST scholars for any of their research projects or preparations for their board exams Specific Aims: